Shifting Suicide Prevention Paradigms: Looking Beyond Clinical Settings

Project Summary: Shifting Suicide Prevention Paradigms: Looking Beyond Clinical Settings
Every 10 minutes one person dies by suicide in the US, a result of a public health epidemic that has increased
over the last 15 years and incurred over $70 billion in medical costs and lost productivity. A common
lamentation in the wake of suicide is, “If we had only known how bad things were.” A crucial scientific gap in
suicide prevention stems from the majority of suicide research relying on individual psychopathology, largely
overlooking meaningful constellations of risk in a broader context of social environmental life disruptions that
commonly precede suicide. Job loss, financial strain, divorce, legal problems, housing instability – these life
disruptions can be semaphores of despair that are misinterpreted as coincidental rather than causal; thus
overlooked as points for timely detection and intervention. I propose a paradigm shift in suicide research by
prioritizing social determinants to develop public health research and prevention through broad, but
strategic, partnerships with industries outside of mental health and health care, including the specific
industries of family law, mortgage foreclosure, and unemployment services. This proposal uses a two-
pronged approach that ventures beyond traditional funding mechanisms by challenging what we typically
consider to be “health” vs. “non-health”-related suicide prevention research and intervention. First, by taking
the tested methodology of psychological autopsy and reinventing it as a social autopsy, we will dive deeply
both into the nature of life disruptions that often precede suicide and the contacts with non-medical services
that a suicide decedent may have made prior to their death. Second, by surveying and interviewing employees
of industries that commonly deal with life disruptions (i.e., divorce, mortgage foreclosure, and job loss), we will
explore their experiences with suicidal clients, such as occupational wisdom and intuition around warning signs
among clients, training around suicide prevention, knowledge about suicide, and approaches they may have
used when working with clients in distress. Seeking unconventional upstream strategies to identify and reach
people at risk for suicide is all the more urgent against the backdrop of the COVID-19 pandemic, which created
historic job loss, relationship strain, and increased potential of mortgage foreclosures. As a researcher trained
in public health sciences, I investigate the social production of health problems, exemplified in my focus of how
social determinants contribute to poor mental health, suicidal ideation, and suicide attempt. My perspective,
coupled with extensive experience in survey data research and efforts in training medicolegal death
investigators, uniquely qualify me to successfully implement these novel approaches to change suicide risk
detection and prevention. True integration of social determinants into suicide prevention research requires
rethinking the problem of suicide as solely a clinical mental health problem requiring clinical solutions, to
suicide as a problem at a social and clinical nexus, thus necessitating both social and clinical solutions.

Public health relevance
Project Narrative: Shifting Suicide Prevention Paradigms: Looking Beyond Clinical Settings The goal of this research is to shift the paradigm of suicide prevention research by prioritizing social determinants through broad, but strategic, partnerships with industries outside of mental health care. By transforming psychological autopsy methodology into social autopsy and surveying and interviewing individuals who work in industries dealing with the depths of life disruption (i.e., family law, mortgage foreclosure, and unemployment processing), this project challenges the status quo of suicide prevention research that is anchored in clinical environments. This unconventional path through non-mental health industries is the chance to bring new perspectives and novel ideas for better, richer, novel data to inform suicide prevention strategies.